Role of Mast cells in Alzheimer's Disease

Mast cells (MCs) play important roles in allergic responses. Recent studies suggest that MCs are also
essential to other inflammatory diseases by releasing inflammatory cytokines, chemokines, and the MC-
specific proteases chymase and tryptase after degranulation. Pharmacological inactivation of MCs prevents or
slows disease progression. Alzheimer’s disease (AD) is the most common cause of dementia and disability in
the elderly. It is the sixth leading cause of death in the U.S., affecting more than 5 million Americans alone,
according to the Alzheimer’s Association. One definitive diagnosis of AD is based on the presence of
extracellular deposition of neurotoxic β-amyloid (Aβ) into senile plaques. Human AD brains have elevated
protease expression, neuronal death and synapse loss, blood-brain barrier (BBB) leakage, and activation of
inflammatory cells such as microglia, astrocytes, and T cells. MCs also present in human AD brains, mainly in
the hippocampus, cerebral cortex, and thalamus, but studies have yet to test whether these cells participate
directly in the pathogenesis or serve merely as another inflammatory hallmark. Our preliminary data
demonstrated that the plasma levels of MC activator IgE and MC granular contents tryptase and histamine
were elevated in patients with early stage AD, indicating enhanced systemic MC activation. Anti-tryptase and
CD117 antibodies detected MC accumulation in the cortex and hippocampus from human and murine AD
brains. Using MC-deficient KitW-sh/W-sh mice and over-the-counter (OTC) MC inhibitor ketotifen, we
demonstrated that the absence or pharmacological inhibition of MCs reduced Aβ deposition and senile plaque
formation in the hippocampus and cerebral cortex, and reduced the numbers of total Iba-1-positive microglia
and CD68-positive phagocytic microglia in these regions in APPSWE-PS1∆e9+/– (APP-PS1) mice that develop
cerebral amyloidosis. Brain tissue extract ELISA showed that the absence of MCs reduced the production of
pathological Aβ species (Aβ1-40 and Aβ1-42). Adoptive transfer of in vitro-prepared MCs into KitW-sh/W-shAPP-PS1-
recipient mice restored cortical and hippocampal Aβ deposition, microglia infiltration and activation, and AD
brain cortex Aβ1-40 and Aβ1-42 contents. A preliminary water T-maze behavior test suggested that MC depletion
improved cognitive decline in APP-PS1 mice. We hypothesize that MCs play a pathogenic role in AD by
releasing pro-inflammatory cytokines and proteases, and MC inhibition with the anti-allergy drugs may become
a novel therapy of human AD. We propose three aims to examine whether MC depletion or inhibition protects
mice from Alzheimer’s disease; to examine whether genetic deficiency of FcεR1 or anti-IgE antibody therapy
protects mice from Alzheimer’s disease and, to establish the mechanistic link between mast cell activation and
mouse Alzheimer’s disease.

Public health relevance
Brain tissues or plasma samples from patients and mice with Alzheimer’s disease (AD) contain increased levels of mast cells (MCs), MC activator IgE, IgE receptor FcεR1, and MC activation products. Our preliminary studies demonstrated that MC-deficiency or inhibition with an over-the-counter human anti-allergy drug Zaditor® improved AD-like pathologies and memory loss in mice. This proposal will test the hypothesis that MCs play a direct role in AD pathogenesis and the human anti-allergy drugs may have therapeutic potential in AD patients.